MAP for Child Health: Using Social Networks to Improve child health and oral health

Early Childhood Caries, along with obesity, are the most prevalent health disparities of childhood in the west.
Both are closely associated with maternal feeding behaviors and cognitions. Educational and behavioral
interventions—most directed at individual mothers—have shown disappointing results in recent decades,
showing limited impact on child health and nutrition. Social-contextual features of the environment--community,
neighborhood and household—are known to profoundly impact child feeding and other risk/protection
behaviors. Working with low income immigrant families at high risk of child caries and obesity, this application
will develop a neighbor-based social network intervention designed to reduce oral caries and obesity by
modifying the social context in which child feeding and oral hygiene behaviors are embedded.
MAP (“Mothers Action Project”) for Child Health—is a 12-month group intervention designed to
decrease the risk of early childhood caries and other nutrition-related disease, among South Asian (SA) toddler
and preschool (TP) children aged 1-5. Research from our team and others finds low income immigrant SA
mothers to be highly vulnerable to influences from the social sphere which increase risks to child health. Many
experience social pressure from elders in their social networks to feed TP children a diet heavy in milk, milk
additives, sweets, and refined carbohydrates— all of which adversely impact oral and metabolic health.
Accordingly, MAP-CH is a novel strategy to modify mothers’ social environment by creating new, health
promoting social networks. During the UH3 Phase of the project, 126 clusters of mothers living in close
physical proximity (12 per cluster, 1512 total) will be randomized 1:1 into intervention and control arms.
Controls will receive health and parenting education materials. The intervention group will participate in a 12-
month, group-based “Mothers’ Club.” Led by a skilled peer facilitator, each mothers’ club will receive an
intervention designed to: 1) build close social ties, social support, and a sense of group identity among group
members; 2) improve knowledge, attitudes and parenting skills related to feeding. The goal is to transform
each ‘Mothers’ Club” club into a meaningful—and lasting-- social network that will support healthy behaviors at
least 12 months beyond the end of the intervention. Network formation and social processes will be monitored
in the pilot phase and throughout the trial using a network diagnostics framework to assess social integration
and network cohesion. MAP-CH is the first child oral health intervention using a social network approach.

Public health relevance
Recent research indicates that conventional health interventions focusing on individual knowledge and behavior are of limited effectiveness. Nutrition based disease in childhood, specifically Early Childhood Caries and obesity, are closely linked to social context and environment. Low income and immigrant children are at particularly high risk. The Mothers’ Action Project for Child Health (MAP- CH) seeks to intervene at the level of social level by creating new social networks for low income South Asian mothers. Mothers living in close proximity will be recruited into Mothers’ Clubs of 10-12 mothers. While receiving health education and skill building over a 12 month program, mothers will engage in activities designed to strengthen social ties among Club members. If successful, the project will provide a model for the development of social network interventions to improve child nutrition-based disease.